ELIMINATION OF AIRBORNE VOLATILE COMPOUNDS THROUGH INCORPORATION OF ADVANCED 3D NANOSTRUCTURED CATALYTIC COATINGS IN ADSORPTION/DECOMPOSITION AIR PURIFICATION SYSTEMS

Project Summary / Abstract
Every year, eight million premature deaths and $5 trillion of societal costs are linked to air
pollution. According to the US EPA, indoor air quality (IAQ) is often two to ﬁve times worse
than outdoor air, which is especially alarming since we spend 90% of our time indoors. In fact,
poor IAQ accounts for 48% of air pollution-related deaths. Submicron-scale pollutants,
particularly volatile organic compounds (VOCs), cause serious chronic illnesses, ranging from
cancer to pulmonary diseases, and reduce worker productivity and student concentration.
Existing technologies rely on pollutant capturing, trapping, and sometimes destruction, but are
all known to have problems from desorption to byproduct creation and ozone generation.
Metalmark Innovations, Inc. is developing an advanced hybrid sorption-catalyst air puriﬁcation
system to capture and destroy such pollutants in an e cient and byproduct-free manner. The air
puriﬁer relies on Metalmark’s proprietary 3D nanostructured thermal catalytic materials that are
uniquely suited for IAQ applications, due to their signiﬁcantly enhanced activity, reduced
operating temperatures and associated reduction in energy consumption, exceptional catalyst
stability (no nanoparticle sintering), and reduced cost compared to their commercially available
counterparts. VOCs are captured in a sorbent module and intermittently released to the catalyst
for complete destruction without release of byproducts. In this Phase II project, we will source
and improve sorbent materials, design the Metalmark catalysts, optimize the sorbent-catalyst
system, produce three generations of air puriﬁer prototypes through an iterative learning
process, and perform at least one pilot study using the ﬁnal prototype. Overcoming the
technological challenges posed in this SBIR Phase II project will propel this innovative indoor
VOC treatment system towards a commercial product for improving the safety of indoor air of
o ces, hotels, schools, homes, and other indoor or in-cabin spaces.

Public health relevance
Project Narrative According to the World Health Organization, poor indoor air quality is linked to high levels of cardiovascular and lung disease, cancers, allergies, asthma, poor cognition, and low productivity, among other diseases and complications. Despite a great need, there is no e cient solution for the elimination of sub-micron pollutants such as volatile organic compounds (VOCs), ultraﬁne particulates (UFPs), and airborne viruses. This proposal seeks to develop a novel and highly e cient air puriﬁcation system consisting of a sorbent and Metalmark’s advanced catalysts in order to capture and destroy tough pollutants, speciﬁcally focusing on VOCs.